Mechanisms of shadow enhancer robustness during development

Development is a remarkably robust process. Developmental gene regulatory networks can
reproducibly pattern the embryo in spite of genetic and environmental variation and the inherent
molecular noise in the system. Shadow enhancers – sets of enhancers that control a single gene and
drive an overlapping spatio-temporal expression pattern – are a pervasive feature of developmental
networks. Despite their apparent redundancy, case studies from Drosophila and mice show that
shadow enhancers are required to drive normal development in the face of temperature stress or
developmental gene knockouts. Systematic surveys find shadow enhancers control most
developmental genes in fruit flies, mice, and humans. Despite their importance, we lack a complete
picture of the features of shadow enhancers that allow them to drive robust developmental patterning.
Many developmental diseases, e.g., autism or diabetes, seem to be caused by a combination of
mutations and environmental influences. Since shadow enhancers seem vital for buffering the effects of
genetic and environmental variation, uncovering their mechanisms may provide insight certain non-
coding mutations combined with environmental stress lead to aberrant expression and disease.
Our long-term goals are to find features of developmental networks that drive robust patterning
and to learn why some mutations in enhancers cause disease while others are harmless. The central
aim of this proposal is to test hypotheses about how the types, numbers, and organization of
transcription factor (TF) binding sites among shadow enhancers impact their ability to drive consistent
gene expression and, by extension, normal developmental patterning. We propose three Aims. Aim 1:
To find functional requirements of shadow enhancers, we will build new sets of shadow enhancers and
measure their mRNA dynamics. Aim 2: To generate predictive models of enhancer function, we will
systematically perturb enhancers in vitro. Aim 3: To reveal the evolutionary trajectories of shadow
enhancers, we will categorize the ages and sequence origins of shadow enhancers.
These aims will connect the organization of TF binding sites in shadow enhancers to their
function, enabling a deeper understanding of how a gene’s regulatory DNA affects its sensitivity to
perturbation. We will use a variety of innovative approaches to achieve our goals, including novel
synthetic transcription factors and high throughput enhancer assays. Given the prevalence of shadow
enhancers in controlling diverse developmental processes, understanding their architecture and origins
may rationalize why some developmental systems, e.g., cranio-facial patterning, are more fragile than
others.

Public health relevance
Project Narrative During development, a fertilized egg divides many times to create the cells that will form the adult animal. To create different cell types, e.g. neurons and muscle cells, each cell expresses different combinations of genes, and errors in this program can cause defects in development. This proposal aims to identify the mechanisms that allow the developmental program to proceed reliably in the face of perturbations.